The Roles of a Novel Immune-Checkpoint Receptor Complex in Driving T Cell Dysfunction in Cancer

Summary
Immune checkpoint inhibitors (ICI) have become the breakthrough therapy in the era of
cancer immunotherapy. However, one of the major challenges is that majority of patients do not
respond, indicating the urgent need to identify and target non-redundant immunosuppressive
pathways. Our preliminary studies have identified a novel cross-talk mechanism between two
immune checkpoint receptors. We hypothesize that this novel cross-talk mechanism drives T cell
exhaustion and impair anti-tumor immune response. We will test this hypothesis by two specific
aims: in Aim 1, we will determine the causal relationship between receptor binding and the
inhibitory effects on T cell activation. In Aim 2, we will investigate how this novel cross-talk
mechanism drives T cell exhaustion and whether blocking this axis can enhance T cell-mediated
anti-tumor immunity. Together, these studies will guide future studies to target this novel axis,
reverse T cell exhaustion, and improve clinical outcomes in cancer patients.

Public health relevance
Narrative: Multiple immune checkpoint pathways control anti-tumor immunity. This proposal investigates a novel cross-talk mechanism between two immune checkpoint receptors. These studies will guide future efforts to develop therapeutic inhibitors that block this axis and enhance anti-tumor immunity.